Caenorhabditis Intervention Testing Program - Data Coordination Center

Contact PD/PI: Phillips, Patrick C. ! ! ! ! ! !& & !# ! ! !& ! & ! # ! ! ! !# ! ! $! !! ! ! ! ! ! ! ! ! !& $! %! ! ! !# ! # !! !& ! ! # ! # ! ! ! ! #! !! ! # & ! ! & ! $ ! ! % ! !# ! # # ! & ! ! ! $ !& ! ! ! #! ! !& ! %! !& ! #!& ! ! ! ! ! ! ! ! ! # ! ! ! $ ! ! ! ! %! # ! ! !& ! ! !! ! !! !! !# ! # ! $ # $ ! !& ! #! ! ! ! & ! ! ! ! ! # ! ' ! ! ! ! $ ! # $ $ ! ! ! ! !! ! $ ! ! #! !! !& ! ! ! # ! $! ! # ! ! !! ! !& Page 6 Project Summary/Abstract

Public health relevance
Project Narrative The Caenorhabditis Intervention Testing Program has been established to identify pharmacological interventions that improve the length of life and/or the quality of aging. By testing genetically diverse animal models, this study seeks to identify interventions likely to be efficacious in a diverse human population. This study may ultimately lead to treatments that protect against physical deterioration, cognitive decline, and disease susceptibility in the elderly human population.